NOSI cloud computing Supplement

Project summary
The goal of this proposal is to explore and test opportunities to enhance data analytics and the reporting of
results to users by incorporating cloud computing and storage capabilities. The overarching goal of the parent
grant, Center for Quantitative Biology (CQB): A focus on -omics, from organisms to single cells is to establish a
nationally recognized, multidisciplinary center that will enhance Dartmouth’s research profile and extramural
funding in the area of single cell ‘omics, both experimentally and computationally. During Phase 1, the
Dartmouth CQB COBRE has established the Data Analytics Core (DAC). The core has been extremely
successful in developing data science approaches and cutting edge pipelines to process and analyze single
cell and spatial transcriptomic data. This includes state of the art downstream analyses.
Operational challenges faced by the core include the high cost of long-term data storage, significant demand
for computing resources to process single cell and spatial data, and the high cost of maintaining state of the art
compute infrastructure. Leveraging cloud computing and storage could increase our computing capacity and
storage while providing a model to make resources available to smaller institutions that may not be able to
invest in local resources. Archival storage costs on the cloud are significantly less expensive than local
storage costs and on-demand access to the latest cloud compute technology would reduce analyst wait times
which would improve turnaround times of data to end users. The overarching goal of this proposal is to
determine the potential of cloud computing to meet the increasing data management and analysis needs of
biomedical researchers with the following specific aims: 1) Train staff in Google Cloud Platform learning paths.
2) Engineer data reduction workflows to operate in the Google Cloud Platform cloud compute environment. 3)
Assess the cost savings and ease of implementing data analyses in the Google Cloud Platform environment.
As genomic data becomes more complex, and analysis becomes more computationally intensive cloud
compute systems will be part of the solution to optimize data analysis infrastructure.

Public health relevance
Project Narrative The increasing size and complexity of genomic datasets, and the ensuing analyses, requires optimization of the research data ecosystem; it is imperative that Cloud computing and storage be part of this solution. The CQB Data Analytics Core has significant experience and expertise in genomic data science and the development of new workflows. In this proposal, we will leverage our expertise to evaluate and optimize cloud compute systems for genomic data science. We will disseminate our findings through training documentation; new advances will be passed onto users through decreased cost and shorter turnaround times.